Decision-making capacity in clinical and research settings

Two notable accomplishments: One, my colleague Gareth Owen of KCL received a grant to study the issue of how the relative new law on DMC in England and Wales is being implemented. Along with an experienced barrister (Alex Ruck-Keene), we have begun reviewing the contested legal judgments of the Court of Protection. Two, Lisa Eckstein and I published a review and analysis of the criteria used for DMC assessment, focusing on how the 'ability to value' is or is not incorporated in various jurisdictions.